GLNARCH 11 Administrative Core

Abstract: Administrative Core
The GLNARCH administrative core is a team who have promoted health sciences careers and
research within the Bemidji Region since 2020. This Great Lakes Native American Research Centers for
Health (GLNARCH) application aligns established partnerships to generate a network of resources for AI/AN
programs as well as support ongoing successful initiatives. We have identified opportunities to establish
synergistic education, training, and research within the Indian Health Service Bemidji Region with increased
focus on including Tribal Colleges and Universities (TCU). The administrative core will assemble the needed
expertise to support the Center’s aims to foster AI/AN participation in biomedical sciences and to advance the
state of knowledge regarding indigenous knowledge systems. In addition to supporting the student
development projects, administrative core activities will improve efforts to interface GLNARCH with both the
communities and AI/AN organizations it serves. The core will also draw upon past evaluation findings to
increase visibility of GLNARCH both online and at community/cultural events such as Powwows and Ojibwe
family circles classes. These initiatives are also aligned to supplement ongoing assessment practices for
GLNARCH.

Public health relevance
Narrative: Administrative Core This Great Lakes Native American Research Centers for Health (GLNARCH) application aligns established partnerships to support health research and AI/AN programs. The Administrative Core is assembled from experienced personnel who have invested in strong working relationships from ongoing NARCH collaborations. This team will coordinate efforts between diverse partners possessing complementary strengths to accomplish GLNARCH aims through efficient use of resources, alignment of common goals, and cultural competence.